ESTROGEN &PROGESTERONE ACTIONS ON VASCULAR MUSCLE CELLS

This is a study at the cellular level of the modulation of vascular muscle reactivity by physiological concentrations of progesterone. Isolated vascular muscle cells are being exposed in vitro to subphysiological doses of E2 and P to test the effectiveness of P alone in reducing vascular muscle reactivity